Novel Self-closing 12F Mitral Valve Repair System to Percutaneously Treat Moderate to Severe Regurgitation Using Transcatheter Edge-to-Edge Repair (TEER) Technique Via Femoral Vein Access.

Project Summary
The MEDFREE® Valve Repair System will innovatively improve upon the current market leading MitraClip
device, while leveraging and building on the proven Transcatheter Edge-to-Edge Repair technique. We aim to
address this vastly unmet percutaneous structural heart market by delivering a simpler, easier-to-use device in
a smaller 12F catheter system that can be used by a single operator. MEDFREE has already completed
preclinical GLP studies in porcine model (Cohort A: n=2, 30 days; Cohort B: n=5, 140 days) with outstanding
results. MRI and Durability (fatigue) studies were also completed with outstanding results. We are now seeking
funds via NIH Commercialization Readiness Program, in preparation for EFS/FIH clinical studies.

Public health relevance
Public Health Relevance Statement / Project Narrative Mitral valve regurgitation affects more than 7 million people or approximately 2-3% of the population in the United States alone, of whom about 3.8 million suffer from moderate to severe regurgitation, with as high as 1.7 million patients in need of immediate treatment, and new diagnoses increasing by about 250 thousand each year. However, only about 50 thousand undergo surgical treatment each year due to the high risk associated with the surgical procedure, and although significantly safer only about 150 thousand patients have undergone catheter based interventional treatment, as the currently available interventional procedures are extremely difficult to perform. In this project, MEDFREE® Inc., will build a safe, easy to use, and innovative 12F percutaneous catheter-based interventional device that leverages the Transcatheter Edge-to-Edge Repair technique to address this severely unmet clinical need, which is a market that is currently estimated to be over $6 billion USD by 2028.